Sex-based contributors to vulnerability to Alzheimer's disease: a multimodal imaging study

Project Summary / Abstract
Nearly 2/3 of people with Alzheimer's disease (AD) are women, and AD has a more aggressive
phenotype in women. Women with AD suffer a faster rate of cognitive and functional decline than do men, and
women are more impacted than men by common genetic variants such as APOE-ε4 which increase AD risk.
The first signs of AD pathology are present decades prior to symptom onset, and multiple lines of research
have implicated the menopausal transition as a time of emerging vulnerability to AD for women. However, we
lack a fundamental understanding of sex differences in the brain circuitry most vulnerable to AD and how these
differences relate to the onset and spread of AD pathology.
The proposed research uses a multimodal imaging approach to understand the impact of both sex and
major sex-based factors on brain circuitry and AD pathology, with two overarching aims.
Our first aim leverages a new prospective cohort study of women and men with early-stage amnestic
and non-amnestic AD, as well as healthy controls, to test hypotheses related to the impact of sex on functional
networks in the brain and the extent to which this mediates faster tau progression in women. We also assess
the impact of sex-based factors, including reproductive period and APOE genotype, on these metrics. We use
innovative task-based functional neuroimaging techniques, plasma AD biomarkers, and ultra-high resolution
second-generation tau PET longitudinally to accomplish these goals.
Our second aim evaluates the relationship between sex, sex-based factors, tau, and functional
connectivity, both in healthy aging and in preclinical and symptomatic AD. We leverage three large open-
source datasets to evaluate specific hypotheses relating sex-based factors to changes in the functional
circuitry targeted in amnestic AD. We then examine associations between functional circuitry changes, plasma
p-tau, and tau PET signal. Finally, we use predictive modeling to identify brain connections which predict focal
early-stage tau pathology, define sex differences in these predictors, and pinpoint the extent to which these
connections mediate the relationship between tau and changes in cognitive performance.
In order to address the disproportionate impact of AD on women, we must first understand the
biological basis for sex differences in AD risk and progression, including the role of the functional connectome
in promoting accelerated tau deposition in vulnerable groups. Successful completion of this work will fill key
gaps in our knowledge of how both sex and specific sex-related factors impact functional circuitry, and in turn
the progression of tau pathology.

Public health relevance
Project Narrative Alzheimer's disease is a public health crisis and is both more common and more severe in women. We will use advanced neuroimaging techniques to identify the impact of sex and specific sex- related factors on brain networks and determine how those changes impact the spread of early- stage Alzheimer's pathology in the brain. Ultimately, this work will fill a major and critical gap in our knowledge by helping us understand how sex-related factors lead to a more aggressive course of Alzheimer's disease in women.